Role of Glutamatergic Neurons in External Globus Pallidus in the Behavioral Deficits in Animal Models of Progressive Dopamine Depletion

SUMMARY
The basal ganglia are a group of subcortical nuclei that regulates motor and cognitive functions. Recent
identification of neuronal heterogeneity in the basal ganglia suggests that functionally distinct neural circuits
defined by their molecular identity and efferent projections exist even within the same nuclei. This distinction
may account for a multitude of symptoms associated with basal ganglia disorders such as Parkinson's disease
(PD). However, our incomplete understanding of the basal ganglia functional organization has hindered further
investigation of individual circuits that may underlie distinct behavioral symptoms in different disease states.
The external globus pallidus (GPe) is a central basal ganglia nucleus that can influence numerous downstream
regions. While the prevailing circuit model assumes that the GPe is a homogeneous population of neurons
transferring the signal in the indirect pathway of the basal ganglia, accumulating evidence suggests that neurons
in the GPe are more heterogeneous than previously appreciated. Although GPe is known to be a nucleus with
GABAergic neurons, we have identified novel cell types expressing VGLUT2, glutamatergic neuronal marker, at
the outer layer of GPe. In our careful anatomical and molecular examination showed that VGLUT2GPe neurons
project mainly to inner part of GPe, making synaptic contacts onto other neuronal populations. Recent evidence
showed that the distinct cell types in GPe may have different roles in modulating basal ganglia circuitry and
associated behaviors. Thus, elucidating the anatomical and functional organization of VGLUT2GPe neurons will
provide novel cellular and circuit information to understand basal ganglia function.
The progressive nature of behavioral deficits associated with PD is very well documented in human patients.
However, what neural adaptations associated with behavioral deficits at different stages of PD are not fully
understood. In this application, we try to address this with two different animal models. First, as in our preliminary
results and recent reports, we will administer different doses of neurotoxin administration to induce different
degrees of DA neuronal loss, which elicit the different behavioral deficits. Second, we will confirm the neurotoxin-
induced PD-related behaviors in MitoPark mice which show the progressive loss of DA neurons. Examining the
circuit adaptation in two animal models will provide an important information on the neural mechanisms
underlying the progressive nature of PD. Therefore, using cutting-edge techniques including optogenetic, genetic
and viral-mediated manipulation, in vivo multi-unit recording, and so on, we will decipher roles of VGLUT2GPe
neurons in behavioral deficits in these two animal models for PD.

Public health relevance
PROJECT NARRATIVE Great attention has been paid to the potential role of the external globus pallidus (GPe) in motor control and the aberrant GPe neuronal activity is closely associated with movement deficits in both PD patients and Parkinsonian animal models. Our preliminary results show that the activity of newly identified glutamatergic neurons in the GPe may contribute to PD-related behavioral dysfunction in dopamine-depleted mice. Thus, we will elucidate the anatomical and functional organization of GPe glutamatergic neurons to improve our understanding of GPe circuitry and its contribution to PD-related behavioral dysfunction in animal models for the progressive PD.